A novel role of mutant p53 in intronic polyadenylation and impairment of DNA repair

SUMMARY/ABSTRACT
The tumor suppressor TP53, known as “the guardian of the genome”, is the most frequently mutated gene in
human cancers and results in the diminished or abolished protective function of its wildtype p53 protein.
Additionally, an extensive spectrum of TP53 missense mutations is observed in cancer and many produce
mutated p53 protein with oncogenic gain-of-function (GOF) activities. Many GOF oncogenic phenotypes are
described, however, it is largely unknown whether and how p53 mutant forms are involved in alternative pre-
mRNA processing. In particular, alternative polyadenylation processing (APA) is well-documented to play roles
in many cancers. We sought to investigate this potential of p53 mutants in lung cancer. Our pilot studies use
patient tumor data in the Cancer Genome Atlas (TCGA) cohort and Next Generation Sequencing (NGS)
experiments on isogenic human p53-null non-small cell lung cancer (NSCLC) H1299 stable transfectant lines
expressing p53-R273H, R175H, H179Q, C238Y, C242F or control vector. Our high-throughput profiling of
polyadenylation sites (PASs) identified that mutant p53 globally regulates intronic polyadenylation (IPA) events,
enabling the production of diverse RNA and protein products. Importantly, many DNA repair genes harbor IPA
sites and we determined that these sites are particularly sensitive to the expression of p53 mutants. These
changes were validated in the TCGA cohort. We also found that the sequence motif for splicing factor (SF)
hnRNPK was the top significantly enriched motif in the upstream regions of IPA sites with increased usage
related to p53 mutants; while hnRNPK expression is upregulated by p53 mutants in NSCLC. Further experiments
show that knock-down of hnRNPK leads to the reduced expression of IPA isoforms of DNA repair genes and
recovery of DNA repair activity. Thus we deduce that commonly occurring p53 missense mutants in NSCLC
impair DNA repair by promoting IPA processing in DNA repair genes with hnRNPK as a key regulator. In this
project, we will validate this hypothesis through two specific aims. In Specific Aim 1, we will test an additional set
of p53 mutants common to NSCLC and include more human cell lines for a comprehensive profile of p53 mutant-
associated PASs in lung cancer. This will determine whether modulation of pre-mRNA processing is a common
characteristic of the majority of p53 mutants found in NSCLC, and also depict the differences among various p53
mutants. In Specific Aim 2, we will characterize the mechanism through which p53 mutants regulate the key
splicing factor, hnRNPK, in IPA processing, and whether inhibition of hnRNPK suppresses IPA processing of
DNA repair genes and affects DNA repair efficiency and apoptosis of cells. Successful completion of this research
will provide a solid foundation in our understanding of the regulatory role of p53 mutant proteins in RNA
processing. This topic has strong potential for detailed long-term studies in the future, perhaps leading to new
insights on how p53 mutants function during tumorigenesis and providing opportunities for novel cancer
therapies for p53-mutant cancer patients.

Public health relevance
NARRATIVE We propose to elucidate a novel mechanism of regulatory and oncogenic roles of p53 mutant proteins that commonly exist in human tumors. We will expand on our initial findings to demonstrate that lung cancer p53 mutant proteins regulate pre-mRNA processing (intronic polyadenylation in DNA repair genes) that contributes to deficient DNA repair of cancer cells. We will investigate the underlying mechanism and illustrate the generalizability associated with different p53 mutants, to lay a foundation in the understanding of the regulatory role of p53 mutant proteins in RNA processing with the potential for development of new cancer therapies targeting p53 mutant lung cancers in the future.